Biobanking and Biomarker Validation (BBV) Core

COBRE Kansas Institute for Precision Medicine (KIPM) – “Biobanking and Biomarker Validation Core”
ABSTRACT
The overall objective of the “Kansas Institute for Precision Medicine” (KIPM) COBRE at the University of Kansas
Medical Center (KUMC) is to advance the customization of healthcare through promoting innovative scientific
discoveries. We have entered the era of Precision Medicine, an initiative recently announced as part of the 21st
Century Cures Act, which is focused on using the molecular basis of diseases to better match patients with the
appropriate therapies and care resulting in improved outcomes. To advance this mission, we have established
the Biobanking and Biomarker Validation (BBV) Core, which combines exceptional expertise and essential
resources within established infrastructure, i.e., Biospecimen Repository Core Facility (BRCF), the Biomarker
Discovery Laboratory (BDL), and the Clinical Molecular Oncology Laboratory (CMOL). Access to the BBV core
will strengthen the biomedical research capacity of our COBRE faculty by enhancing their research base and
infrastructure capacities. To advance precision medicine research within this COBRE, the BBV core will 1)
Provide centralized and uniform collections, processing, and storage of tissue and bodily fluids and tissue-related
histology services; 2) provide integral and comprehensive protein and nucleic acid isolation, quantitation, and
molecular characterization services; and 3) provide fully customizable molecular testing and genomic-based
sequencing services. The BBV core is designed to centralize these essential services that will in turn provide
support to the KIPM COBRE faculty, pilot grantees, and researchers within our region and beyond. Given the
level of sophistication of the materials and services required for the range of studies proposed within the KIPM
COBRE, a highly integrated BBV core is not only cost effective but an absolute necessity. The BBV core
eliminates redundant infrastructure and expense required for each researcher to develop their own capabilities
or to search for the necessary research expertise. The BBV core will enable multiple COBRE faculty and future
pilot grantees, access to state-of-the-art facilities and laboratory expertise, thereby further reducing the relative
cost of their studies. Furthermore, the BBV core will continue to provide in-kind technical staff-support and
banking resources, which help the KIPM COBRE faculty to more effectively utilize their funding, both institutional
startup and COBRE support. The success of the BBV core and ultimately the COBRE faculty is essential to
advancing the mission of the KIPM to advance the customization of healthcare through promoting innovative
scientific discoveries.